Designing biomaterials with temporal control of proteins via genetic fusion with coiled coil peptides for enhanced bone repair

Project Summary
The use of bone morphogenetic proteins (BMPs) shows promise as therapeutics for improving bone repair;
however, high supraphysiological concentrations required for the desired osteoinductive effect, costs, and
patient variability have prevented the full advantages of BMP-based therapeutics from being realized. Thus,
there is a clinical need to develop new bone tissue engineering approaches that promote osteogenesis at
lower BMP doses and prevent adverse side effects. In the native extracellular matrix (ECM), BMP is tightly
bound by proteins and glycosaminoglycans with its presentation regulated in time to enhance bioactivity.
Furthermore, researchers have shown significant synergies with other signaling molecules, such as cell-matrix
or cell-cell adhesion ligands. To mimic these interactions, a number of elegant approaches based on
photopatterning and orthogonal chemistries have been developed for presenting biomolecules. However, these
approaches rely on highly customized chemical reactions (which may be difficult to implement with full length
proteins) and are generally restricted to 1-2 biomolecules. They are also often based on photocleavage
reactions for temporal control, which precludes their reversibility over multiple cycles. Given the complexity of
the extracellular environment (e.g., the stem cell “niche”) in controlling the fate of cells, a general platform that
can control three or more proteins with user-defined, temporal control over protein immobilization would be
invaluable for teasing apart the factors that control behavior like cell proliferation, migration, differentiation, and
new tissue formation, especially in the context of BMP-induced bone repair. With this in mind, the proposed
studies will 1) provide new insight into the temporal role of cell adhesion and growth factor binding during BMP-
induced osteogenesis and 2) identify key biomaterial design parameters for promoting bone repair.

Public health relevance
Project Narrative The use of bone morphogenetic proteins (BMPs) shows promise towards therapies for improving bone regeneration in patients with trauma or disease; however, these approaches are limited by the high concentrations that are necessary for the desired therapeutic effect. This project aims to develop a biomaterial scaffold with temporal control over protein presentation to enhance BMP-induced bone repair. If successful, this approach may lead to new treatments for patients that will decrease recovery times and costs.